Physical Activity Monitoring In the LIFE Study Using the Actigraph Accelerometer

The major intervention in the LIFE pilot study for participants assigned to the exercise group will be walking. According to the treatment protocol, during the first six months as much as half of their increase in walking will be carried out at home or in a non-supervised setting. During the second six months, at least 75% of the assigned walking will be non-supervised for most participants. To know if this intervention was accomplished, LIFE investigators need documentation that a significant increase in walking took place in the exercise participants versus the healthy aging class participants. Currently the protocol includes the use of pedometers, logs and the CHAMPS questionnaire to inform the investigators about the activity profile of each study participant. While all of these measurement tools are likely to provide useful data, none have been proven to provide an accurate and objective assessment of the daily physical activity profile of older, somewhat frail persons. The Actigraph is a small solid-state accelerometer/recorder (6.6 x 4.3 x 2.5 cm., 70 grams) that can store the number of times it moves x the rate of movement change (acceleration) on a continuous basis for up to a month (approximate battery life). It stores these counts for specified times intervals, usually set at one-minute. For LIFE, this monitor will be worn on the right hip of each participant. The trial is now complete and actigraph data are being cleaned and analyzed. A paper on the results has been published and other analyses are under way.